NIAAA Repository/Screening Database Management and Research

As of this report, the NIAAA Repository/Natural History Database includes phenotype and/or genomic data on 3470 individuals. Phenotype data include psychiatric diagnoses, a variety of alcohol-related assessments and measures including lifetime and recent consumption and alcohol response phenotypes, personality and impulsivity measures, depression and anxiety symptoms, current and early life stress and trauma, aggression, suicidality, smoking, IQ, sleep quality, pain, and overall quality of life. Laboratory/biochemical measures are also available. Genomic data include: 1) large-scale single nucleotide polymorphism (SNP) genotyping performed using Illumina arrays; 2) exome sequencing of a subset of subjects, both via a partnership between the Clinical Core Laboratory of the OCD, and the Laboratory of Neurogenetics (NIAAA); and 3) DNA methylation data for a subset of subjects via a partnership with the Laboratory of Neurogenetics.

All NIAAA PIs and their research staff are encouraged to submit data requests in order to conduct research projects and analyses using the shared NIAAA Repository/Natural History Database. Projects are logged and the status is tracked from initial request to manuscript publication. In addition, Human and Genomic data are shared via BTRIS and other mechanisms, including collaboration with NIH-supported consortia (PGC Alcoholism, ENIGMA) to ensure data sharing.

I. Projects (4) resulting in manuscripts published within the past year:

Association between FXYD2 and DRD2 genes and measures related to dopamine signaling in alcohol use disorder

The role of C-Reactive protein in alcohol use disorder

Quality of life among patients with alcohol use disorder and healthy controls: Examining the effects of genetics, childhood adversities, drinking histories, and lifetime suicidality

Chemosensory alterations and impact on quality of life in persistent alcohol drinkers

II. Projects (4) resulting in manuscript submissions, revisions, or publications in press, within the past year:

Electrocardiogram and other cardiovascular indicators of at-risk alcohol drinking

Association of early life and current stressors with alcohol use and BMI

Early life stress in inpatient AUD and non-AUD controls (fourth manuscript from this overall project)

Comparison of resting state functional connectivity, alcohol consumption patterns, and CASE behavior as a function of CHRNA5 genotype

III. Projects (8) with manuscripts in preparation:

Immunoglobulin levels in alcohol use disorder and their association with comorbid major depressive disorder and chronic stress

Latent profile analysis of impulsive and compulsive drinking

Reporting of adverse childhood events as a function of race/ethnicity and gender and their influence on drinking behaviors

An investigation into the role of metabolic biomarkers in the anticipation of reward in treatment seeking alcoholics (second manuscript from this project)

Connor-Davidson Resilience Scale (CDRS): association with childhood trauma, alcohol-related outcomes and psychopathology

Association between dopaminergic genetic variation and IV alcohol consumption in the lab and in the field

Clinical pain severity in AUD: impact of childhood trauma and current stress, and an examination of sex differences

The impact of trauma timing and load on brain-behavioral measures of Alcohol Use Disorder

IV. Ongoing projects (11) still in progress:

Individual differences of Taste Receptor Genes and their association with alcohol-and food-related phenotypes and behaviors. Data analyses are ongoing.

Comparison of resting state functional connectivity, alcohol consumption patterns, and CASE behavior as a function of CHRNA5 genotype. Data analyses are ongoing.

Early life stress effects on emotional facial expression processing in individuals with alcohol use disorder. Data analyses are ongoing.

Neurobiological substrates of racial/ethnic disparity in alcohol use disorder: characterization of vulnerability/resilience via imaging, genetics, and biobehavioral information. Data analyses are ongoing.

Characterization of drinking patterns in alcohol use disorder by Timeline Follow-Back variability analysis: association with craving, other substance use, psychopathology, and alcohol-related liver conditions. Data analyses are ongoing.

An evaluation of binge drinking definitions and measurement: assessing the importance of consumption duration. Data analyses are ongoing.

Analysis of weight trends and micronutrient stores in patients admitted to an inpatient alcohol rehabilitation program. Data analyses are ongoing.

Differences in hypothalamic-pituitary-adrenal axis responses to alcohol withdrawal-induced stress in black and white individuals with and without alcohol use disorder. Data analyses are ingoing.

Interactions between the UPPS-P impulsivity facets and alcohol related outcomes. Poster presented, follow-up analyses ongoing.

Differences between those with only AUD and those with AUD and depression with an emphasis on the ANA framework. Poster presented at APA, follow-up analyses ongoing.

Trends in alcohol use and misuse and related phenotypes: NIAAA natural history protocols, 2005 to the present. Data analyses ongoing.

V. Other New projects (11) initiated within the past year:

Correlation of polysubstance use with severity of alcohol withdrawal

Modeling patterns of adulthood life events and their associations with mental health, well-being, and alcohol-related outcomes

Phenotypic relationships characterizing impaired control over alcohol use

Neurofunctional domain predictors of recovery in treatment-seeking AUD patients

Prevalence of oral health and smoking, and the relationship between stress, early life events, and oral health in a sample of treatment-seeking individuals with alcohol use disorder

Phenotypic differences between comorbid AUD/PTSD and individuals with only AUD or only PTSD, and effects of childhood trauma

Associations between evaluation of the liver with a hepatologist and relapse to alcohol in treatment seeking patients with AUD

Adverse childhood experiences, psychiatric comorbidity, and the response to stress and alcohol cues in individuals seeking treatment for alcohol use disorder

Examining the relationship between received social support and resting state functional connectivity within treatment seeking alcohol use disordered populations

The buffering role of resilience in the association between multidimensional impulsivity and problematic drinking

Interaction of alcohol use disorder and genetic predisposition on iron metabolism and related outcomes

VI. Other Progress

The collaboration with The Alcoholic Hepatitis Network project (AlcHepNet) is ongoing. Data were shared with the group to be used in investigations of genetic variation and new treatments in alcoholic hepatitis, and a manuscript is in preparation

A new collaboration is being established with Jaymin Upadhyay of Boston Children's Hospital and Harvard Medical School, to study physical and emotional pain during the protracted withdrawal state of alcohol use disorder